The MYC-SWI/SNF connection in cancers defined by SMARCA4 mutations

PROJECT SUMMARY/ABSTRACT
Approximately 20% of all cancers harbor deleterious mutations to subunits of the SWI/SNF chromatin
remodeling complex. Determining how SWI/SNF subunit loss drives malignancy in cancers defined by SWI/
SNF subunit mutations has remained an active area of research. A newly emerging area of study in these
tumor types involves the intersection of SWI/SNF with established oncogenic pathways as a means to
control tumor suppression and formation—with one of these oncogenic pathways implicating the
oncoprotein transcription factor, MYC. As a transcription factor, MYC binds to and regulates expression of
thousands of genes, which is dependent on a suite of cofactor interactions MYC makes with chromatin
regulators, coactivators, and corepressors. In our previous studies, we discovered that the SNF5 subunit of
SWI/SNF can directly antagonize MYC function at the level of chromatin and in SNF5-null rhabdoid cancer
cell lines, MYC can interact with additional SWI/SNF subunits to promote MYC target gene expression. In
this application, we posit that additional SWI/SNF subunits beyond SNF5—specifically the BRG1 subunit of
SWI/SNF—also function in tumor suppression through directly impeding MYC functionality. This implies that
loss of BRG1 in cancer, leads to changes in MYC and/or SWI/SNF activities that promote the cancer state.
Support for this hypothesis comes from evidence that activation of MYC target genes is present in BRG1-
null tumors and reintroduction of BRG1 suppresses cancer processes and growth, which is proposed to be
due to SWI/SNF interactions with transcription factors such as MYC and AP-1. Published data also indicate
that re-expression of BRG1 antagonizes MYC activity on chromatin, suggesting that BRG1—like SNF5—
can control MYC function. Overall, these data provide the rationale for examining the MYC-SWI/SNF
connection in BRG1-null cancers and point to the possibility there there are broad oncogenic mechanisms
at work across cancers defined by SWI/SNF subunit mutations. Specific Aim 1 will use a battery of genetic
and genomic approaches to determine how MYC and SWI/SNF regulate genomic activities in diverse
BRG1-null cancer cells. Specific Aim 2 will directly challenge the hypothesis that BRG1 can temper MYC
function across the genome. Completion of these studies will expose the oncogenic mechanisms that
maintain the BRG1-null cancer state and challenge the significance of SWI/SNF in controlling MYC target
gene expression.

Public health relevance
PROJECT NARRATIVE Deleterious mutations to subunits of the SWI/SNF chromatin remodeling complex occur in approximately 20% of all cancers and lead to changes in SWI/SNF function that drive malignancy. This goal of this project is to probe the impact of SWI/SNF on the functionality of the oncoprotein transcription factor MYC in cancers defined by mutations to the SMARCA4 gene, which encodes the BRG1 subunit of SWI/SNF. Completion of this work will expose the oncogenic mechanisms at work BRG1-null cancers and challenge the significance of SWI/SNF in controlling MYC target gene expression.